Core C: Biostatistics Bioinformatics Core

PROJECT SUMMARY
The purpose of the Biostatistics and Bioinformatics Core (BBC) is to provide a comprehensive, multi-
disciplinary resource of expertise in biostatistics and bioinformatics. Members of the BBC will collaborate
closely with investigators from each project in translating their hypotheses into testable statistical hypotheses
and address the corresponding aims at all levels of investigation. This consists of designing basic and animal
experiments, managing and maintaining the resulting data, data analysis and statistical and bioinformatics
inference, and formulating new hypotheses based on discoveries arising from exploration and visualization of
the integrated data. The BBC serves as a focal point from which investigators may draw statistical and
bioinformatics expertise for planning, management and analysis of their studies. It also develops, tests and
implements various techniques of statistical analysis, including mathematical modeling, applicable to cancer
research. Types of research supported include basic science and translational research. The large volume of
information to be generated in the proposed research projects and cores requires computer-based tools for the
coordination of efforts and the management of data. The primary role of the BBC will be to establish a
centralized relational database system and data management structure that facilitates the entry, storage and
retrieval of all data generated by the program project, and permits the controlled exchange of information
across the several projects and cores. De-identified information will be available to all investigators associated
with this program project. Due to the sensitive nature of the information stored by this Core, we will take
extensive precautions to protect the confidentiality of participants. All IRB and HIPAA regulations will be strictly
enforced. By providing data access to investigators, sharing technical capabilities, and ensuring the quality of
the data, the data management component of this core will facilitate achievement of the project aims and
encourage exploratory analyses beyond those stated.

Public health relevance
PROJECT NARRATIVE The Biostatistics and Bioinformatics Core serves as a comprehensive, multi-disciplinary resource of expertise in biostatistics and bioinformatics to assist investigators from all projects to design their experiments, manage and maintain the large volume of data, make inference regarding the stated aims, and formulate new hypotheses based on discoveries arising from exploration and visualization of the integrated data.